Vector Core

The Vector Core's primary function is to supply recombinant Adeno-associated (rAAV) viral vector stocks that are used by all subprojects of this program. In addition to supplying research grade rAAV, the Core will develop a modified scalable baculovirus production system for rAAV1 that will be used for the anticipated clinical trial described in Project 1. Finally, the Core will supply GLP grade rAAV1 for preclinical toxicology studies and primate studies for Project 1.

Public health relevance
The Vector Core is essential to all of the projects in this Program Project grants because it will supply high quality research grade rAAV vectors. In addition, it will develop a high volume baculovirus production method for the clinical trial anticipated from Project 1 as well as produce the preclinical GLP material for toxicology testing for Project 1.